A Targeted DNA Adductomics Approach for Analyzing > 100 DNA Adducts

ABSTRACT
Endogenous metabolism and environmental exposure can give rise to DNA adduct formation. Robust
measurement of the levels of DNA adducts can offer important knowledge for understanding the mechanisms of
DNA repair and allow for assessment of human exposure to genotoxic chemicals. We reason that a scheduled
selected-reaction monitoring (SRM) method for DNA adduct analysis will facilitate high-throughput analysis of
the DNA adductome. The long-term objective of this application is to develop a targeted DNA adductomic assay
for assessing quantitatively the DNA adducts induced by various endogenous and exogenous sources of DNA
damaging agents, and to employ the method for monitoring human exposure to complicated environmental
pollutants and for investigating DNA repair. The proposed research is organized into three Specific Aims. In Aim
#1, we will establish an SRM library for targeted quantitative measurement of the DNA adductome. In Aim 2, we
will profile comprehensively the DNA adductome in lung tissues of mice exposed to particulate matter air
pollution. In Aim 3, we will assess the oxidative metabolism and repair of alkylated DNA lesions by Fe2+- and 2-
oxoglutarate-dependent oxygenases. The outcome of the proposed research will provide the scientific
community with a high-throughput platform that allows for monitoring the DNA adductome and will afford novel
insights about the repair of alkylated DNA lesions.

Public health relevance
PUBLIC HEALTH RELEVANCE The research proposed in this grant focuses on the development and applications of a high-throughput method for monitoring quantitatively more than 100 DNA damaging products. The outcome of the proposed study will improve our understanding about the repair and adverse human health consequences of DNA damage.